cell Function & Pathophysiology Project

The Cell Function and Pathophysiology Core will be led by Dr. Ted Dawson and will function to determine disease-associated phenotypes from the differentiated PDiPS cell lines. In addition, the members of the Cell Function and Pathophysiology Core will be responsible for developing the existing phenotypic assays into a format amenable for large-scale drug screening. In conclusion, we think that the talented clinical investigators and translational scientists that comprise our current PDiPS Consortium are well placed to transition our groundbreaking work into a U24 format that meets the criteria outlined in the new RFA (RFA-NS-11-011, see Fig. 3 for Milestones).